Using speech entrainment to predict conversational outcomes in autistic adolescents

ABSTRACT
Autism is largely defined by difficulties engaging in successful conversation. Yet there are currently no valid
methods for quantifying conversational outcomes for this population. Accordingly, it is extremely difficult for
clinicians to identify difficulties, set appropriate goals, track progress, and evaluate treatment efficacy. This is
particularly detrimental during adolescence, a period of life when conversation plays a markedly pivotal role in
establishing friendships and emotional closeness with others. Speech entrainment provides a valid and
quantifiable measure of conversational outcomes. Speech entrainment is the tendency for interlocutors to modify
their speech behaviors to align with the behaviors of their conversational partner. Key here is the extensive body
of theoretical and empirical research documenting a robust relationship between speech entrainment and real-
world metrics of conversational success. Speech entrainment has been linked to conversational efficiency and
quality, better rapport, and stronger interpersonal relationships. The majority of this research has focused on
adults. However, in our previous NIH-funded research, we created and validated a robust methodology for
measuring entrainment in neurotypical adolescents and demonstrated its ability to predict tangible metrics of
conversational success. Nevertheless, an understanding of entrainment in autistic adolescents is lacking. In our
previous work, we demonstrated differences in the entrainment patterns of autistic and neurotypical adults in
highly controlled laboratory settings. Pilot data collected for this project from 28 dyads in naturalistic peer-based
conversations suggests similar differences in adolescence as well. However, beyond this data, research in this
area is virtually nonexistent. Thus, addressing this gap represents the requisite first step towards our ultimate
goal—to develop a valid and objective measure of conversational success that can be used to optimize treatment
outcomes for autistic adolescents. Here, we propose an investigation focused on gaining a comprehensive
understanding of entrainment in autistic adolescents and determining the relationship between entrainment and
real-world metrics of conversational success in these individuals.

Public health relevance
PROJECT NARRATIVE There are currently no valid measures of conversational success for autistic adolescents. Speech entrainment (i.e., the tendency for interlocutors to align their speech behaviors with one another to optimize conversational outcomes) enables us to quantify conversational success. In this project, we focus on gaining a comprehensive understanding of the entrainment patterns of autistic adolescents as a first step towards our ultimate goal—to develop a valid and objective measure of conversational success that can be used to optimize treatment outcomes for autistic adolescents.